Understanding the Science of Effective Mentorship Networks for Underrepresented Researchers

Project Summary/Abstract
This administrative supplement seeks to build upon our MIRA R35 award by developing and evaluating an
innovative online course aimed at building mentorship networks within the biomedical sciences, particularly
through the National Research Mentoring Network (NRMN). Aim 1 of the proposal is dedicated to the creation
of a comprehensive five-module course designed to equip more than 300 researchers across all career stages
with the skills necessary for effective mentorship and network building. These modules will cover foundational
concepts of mentorship, strategies for self-assessment and goal setting, practical approaches for forming and
sustaining mentorship networks, and insights into becoming impactful mentors themselves. Aim 2 focuses on
evaluating the shift in participants' perceptions regarding the importance of mentorship and diverse mentorship
networks, utilizing pre- and post-course surveys to measure impact. Aim 3 will assess how the course
influences the development and enhancement of mentorship networks, tracking the formation of new
connections and the improvement of existing ones, thereby facilitating a more inclusive and equitable
biomedical research environment for potentially thousands of researchers. Through this supplement, we aim to
address critical gaps in mentorship practices, fostering a culture of supportive, productive mentorship networks
within the NRMN and beyond.

Public health relevance
Project Narrative Building upon our MIRA R35 award, this administrative supplement introduces a novel online course designed to empower biomedical researchers to foster robust mentorship networks through the NRMN platform. It aims to enhance research outcomes and bridge mentorship gaps of more than 300 researchers—potentially thousands—contributing to a more diverse biomedical workforce.